Polygenic Risk Scores for Healthier African American Families

PROJECT ABSTRACT
To advance the health and care of children, as in eMERGE II & III, CCHMC will assemble a birth cohort in
eMERGE IV, ascertained on pregnant or recently delivered self-identified African-American (AA) women and
their babies, along with the willing fathers and siblings. The eMERGE IV collection will be the inaugural effort in
a new CCHMC initiative, a birth cohort of mother and baby dyads called My Genome and Me, Cincinnati
(MGMC), conceived to develop an understanding of the genomics that informs health and disease risk, beginning
at birth and continuing across the lifespan with dyads randomized at enrollment to genotyping with return of
results as neonates or later as older children. Our eMERGE IV project will directly grapple with the ethical issues
raised by return of results to families with different considerations operating in babies, siblings and parents
regarding the particular phenotypes being studied. For eMERGE IV, as site-specific phenotypes, we nominate
Asthma, Atopic Dermatitis, Obesity, Hypercholesterolemia, Hypertension, Prematurity, and Breast Cancer. We
will exploit the work done that will enable developing polygenic risk scores (PRSs) and genomic risk estimates
(GREs) for these conditions in addition to the 15 others chosen by the eMERGE IV Network and anticipate
developing consensus across the Network for the PRSs and GREs applied. The care of families will exploit the
harmonization of the electronic health records between the adult and pediatric hospitals, which has been
achieved with the Maternal and Infant Data Hub (MIDH) using the Observational Medical Outcomes Partnership
(OMOP) common data model. For data quality control we will evaluate discrepancies between eMERGE IV
genotyping and low read depth coverage (LRDC) genotypes (LRDC sequencing will be at CCHMC expense.)
We will collect preferences and attitudes of our local AA community with respect to genomic results and return
of results. We will develop health risk-reducing recommendations and return GREs with and without actionable
PRSs to assess the influence of PRSs on the adherence to risk-mitigating recommendations. We will use SMART
on FHIR (Substitutable Medical Applications, Reusable Technologies and Fast Healthcare Interoperability
Resource) through the electronic health record (EHR)-integrated clinical decision support (CDS)-Hooks
framework to provide CDS to both the adult and pediatric EHR systems. We will periodically revise PRSs and
GREs and return changes when indicated. CCHMC will provide LRDC sequencing from >17,000 DNA AA
samples from children in the CCHMC biobank and ≥50,000 subjects in total for genotype generation and
mitochondrial DNA variant analysis. Federated geocoding will be available to all eMERGE IV sites from CCHMC.
To disseminate genomic practice within CCHMC, across the Network, and in general, CCHMC will provide
services to advance PRSs and GREs for specific conditions, starting with acute lymphoblastic leukemia, migraine
headache, and suicide. In sum, CCHMC presents an aggressive program use genomic medicine to advance
toward better health outcomes focused on underserved AA dyads of neonates and mothers with their families.

Public health relevance
Project Narrative Cincinnati Children's (CCHMC) proposes to join eMERGE IV by enrolling of local Cincinnati African-American newborn babies and their mothers with available fathers and brothers and sisters to develop predictions of their risk for Asthma, Atopic Dermatitis, Obesity, Hypercholesterolemia, Hypertension, Prematurity, and Breast Cancer (along with 15 disorders chosen by the eMERGE IV Network and disorders chosen by CCHMC Faculty) using genetic variation, environmental factors, and family history. We will test whether knowledge of having a higher genetic risk for these disorders will motivate closer adherence to health recommendations made to reduce disease risk.